Genetic analysis of pleiotropic drug resistance

Candidemias represent the 4th most common type of bloodstream infection and with only three
commonly used antifungal drugs available, treatment options are threatened by drug resistance.
Infections linked to Candida glabrata represent the second most common type of candidemia and have
been increasing since the early 2000s. C. glabrata exhibits a robust ability to acquire resistance to azole
drugs, the most commonly used class of antifungal compounds. Isolates that are azole resistant are
routinely found to contain gain-of-function (GOF) mutations in the PDR1 gene, encoding a transcription
factor that is a central regulator of drug resistance. These GOF forms of Pdr1 drive constitutively high
levels of transcription of target genes. Central among these is the ATP-binding cassette transporter-
encoding CDR1 locus. Cdr1 is a drug efflux pump that prevents the accumulation of toxic azole levels in
the cell. The target of azole drugs is the lanosterol -14 demethylase enzyme encoded by the ERG11
gene. ERG11 transcription is induced by azole drug challenge through the action of the Upc2A
transcription factor. The transcriptional regulatory circuits defined by Pdr1 and Upc2A have previously
been treated as separate pathways to azole resistance. We recently discovered that Upc2A controls
transcription of both PDR1 and CDR1, indicating the presence of a physiological tie between these
regulatory networks. In this proposal, we plan on dissecting the mechanism(s) used by Pdr1 to activate
gene expression and dissect the interaction between Pdr1 and Upc2A at the levels of target gene DNA-
binding and transcription. In aim 1, we will determine the functional contribution made by coactivator
proteins that we have found by mass spectrometry to co-purify with Pdr1. Epitope-tagging and gene
disruption alleles will allow determination of how these proteins interact with and modulate the ability of
Pdr1 to regulate gene expression. Aim 2 will identify protein targets interacting with the Pdr1 C-terminal
transcriptional activation domain that are responsible for recruitment of the transcriptional Mediator
complex and induction of gene expression. We will also use cross-linking approaches to identify proteins
that interact with this domain as well as potential negative regulatory domains within Pdr1. Finally, we
will use a combination of chromatin immunoprecipitation coupled with high-throughput sequencing and
RNA-sequencing to determine the mutual impact Pdr1 and Upc2A have on co-regulated genes. We will
also disrupt other transcription factor genes regulated by these two factors to identify the larger suite of
genes involved in the transcriptional response to azole drug challenge. Our finding of the connections
between Pdr1 and Upc2A indicates that these factors cooperate to confer azole resistance as part of
their normal function. Understanding of the molecular basis of this cooperation will provide insight into
new vulnerabilities to use to attenuate drug resistance.

Public health relevance
Candida glabrata is the second major cause of candidemias owing in part to its ability to develop high level resistance to azole antifungal drugs. This application is focused on analyzing connections between the two major pathways for azole resistance.